Administrative Core

The Administrative Core is the umbrella organization for the Program Project. The purpose of this core is to provide programmatic direcfion and promote interacfion between the investigators through regular internal meefings and through an annual meefing with a scientific advisory committee that will be selected. It will coordinate communicafions with the National Institutes of Health, and will provide help with budget management. The Administrative Core is led by the Program Director, Dr. Mitchell Kronenberg. Co-Director Dr. Yun-Cai Liu will assume the role of Director in Dr. Kronenberg's absence. Research Administrative Assistant (RAA) Ms. Jennifer Lagos will coordinate meefings and communicafions with the four principal invesfigators and their assistants, with members of their research groups, with Institufional review boards and with the Scientific Advisory Committee.

Public health relevance
The Administrative Core ofthe Program Project will facilitate interactions between the projects and with the Nafional Institutes of Health.